TISSUE AND BLOOD BANK CORE

The Tissue and Blood Bank Core for the Lung Cancer SPORE will serve as a shared resource for the main Research Projects and for the Career Development and Developmental Research Programs. The Core will collect, process, store and distribute tissue and body fluid specimens from patients diagnosed with lung cancer or with suspected lung cancer, and from subjects who are members of the PLuSS cohort and the PLuSS High-Risk Sub-Cohort. Triage and distribution of all specimens will be prioritized according to a plan established with all SPORE investigators, and approved by the Tissue and Blood Bank Core Pathologists. The Core will procure and triage fresh human lung tissue, including tumor, adjacent uninvolved, and normal tissues distal from the tumor, and bronchial biopsies of the airway, from lung cancer patients undergoing resections or bronchoscopies, as well as individuals undergoing these procedures for reasons other than ung cancer. After triage under sterile conditions, tissues designated by the Core Pathologist as normal or abnormal will be either immediately distributed to investigators for tissue culture, protein analysis, RNA analysis, or DMA analysis, or will be stored for future use. Lymphocytes, serum, and plasma will be separated from other blood components and used immediately or stored for future analysis. Fragments of tissue will also be formalin-fixed for paraffin embedding. Fixed tumor blocks from patients enrolled in clinical trials will also be obtained and stored by the Core. Some paraffin embedded specimens will be sectioned, examined by a Core Pathologist and normal and abnormal area separated by microdissection;others will be used for the preparation of tissue microarrays (TMAs). The Core will also carry out EGFR mutation analyses on microdissected tumor specimens and will utilize tumor tissue sections for EGFR amplification analyses by fluorescence in situ hybridization (FISH). The Core will also carry out routine and special pathology such as immunohistochemistry, morphometry, digital imaging and photography. Tissue/fluid procurement will be linked to ongoing SPORE projects and modifications will be made as necessary to meet any changes in SPORE research goals. All tissues will be collected through IRB-approved protocols on which Tissue and Blood Bank Core pathologists will be co-investigators. The Tissue and Blood Bank Core will take advantage of the UPCI infrastructure already existing for procurement of tissue and will not duplicate it.